FEEDBACK CONTROL OF GROWTH HORMONE SECRETION

The Investigators continues to study the relationship between pubertal development and the secretion of and sensitivity to growth hormone. In adolescent boys and girls IGF-1 levels were found to be more dependent on sex hormone levels than on nocturnal growth hormone secretion. This difference was not dependent on puberty-related changes in the IGF binding proteins IGFBP-1, IGFBP-2, or IGFBP-3. This finding was presented at the Annual 1994 meeting of the Endocrine Society and is being prepared for publication.